Roles for mismatch repair proteins in maintaining Genome stability

Project Summary Crossing over between chromosome homologs is critical for their segregation in Meiosis I. In baker's yeast most meiotic crossovers (COs) are formed in an interference-dependent pathway in which double Holliday junctions (dHJs), stabilized by Msh4-Msh5, are resolved through the actions of STR helicase/topoisomerase, Exo1 nuclease, and the DNA mismatch repair MutLγ (Mlh1-Mlh3) endonuclease. Our work is focused on creating a model to explain how MutLγ, in a mechanism that is currently unknown, acts to resolve dHJs. This work will help us understand the molecular defects that underlie human infertility and hereditary forms of colorectal cancer. Our studies indicate that MutLγ endonuclease is activated in DNA mismatch repair (MMR) and crossing over through the formation of a MutLγ filament. We are testing this model in three Aims. In Aim 1 we will employ electron microscopy and DNA binding assays to analyze yeast MutLγ polymerization properties. Endonuclease assays will be performed to measure MutLγ activity on DNA substrates containing mismatch loops and structures predicted to be recombination intermediates such as HJs and branched DNA structures. These studies will be performed with MutLγ alone and in the presence of interacting factors. Residues required for MutLγ interactions with these substrates and endonuclease cleavage sites will be mapped. We will also perform single-molecule analyses to determine how MutLγ binds to DNA substrates such as loop mismatches and the role that the Mlh3 linker domain in MutLγ plays in this process. In Aim 2 we will identify meiotic factors that interact with yeast MutLγ. Using a structure-function approach we identified five CO proficient, MMR defective alleles and one CO defective, MMR proficient, mlh3 allele that does not disrupt MutLγ endonuclease activity. Our 76 allele set provides a foundation for experiments that examine interactions between MutLγ and STR, Exo1, Msh4-Msh5, Zip3 and newly identified components. We will examine the biochemical functions of Mlh1-mlh3 complexes containing mlh3 null and separation of function mutations. Mutant complexes defective in specific biochemical activities (DNA binding, ATPase, endonuclease) will be used as baits in genetic suppression (high copy, reduced dosage) approaches involving a large set of meiotic factors. Meiotic extract pull-down assays using wild-type and specific Mlh1-mlh3 complexes will be performed in parallel. Finally, we will perform epistasis analyses between mlh3 mutants and meiotic components to create a MutLγ network to be tested in biochemical assays (Aim 1). In Aim 3 we will study why mouse MutLγ has a linker domain seven times larger than the yeast domain. Linker domains in Mlh proteins undergo conformational changes and mediate DNA binding; interestingly genetic and cell biology studies suggest that the mouse linker also contains novel activities. We will purify mouse MutLγ and linker domain deletion mutants and will analyze them in assays developed for yeast MutLγ in Aim 1. This work involves a collaboration with Paula Cohen, who will perform genetic and cell biological analyses of mouse MutLγ.

Public health relevance
Narrative DNA mismatch repair (MMR) proteins facilitate crossing over between homologs to ensure proper Meiosis I chromosome segregation. In humans, failures in meiotic chromosome segregation result in aneuploidy syndromes (at least 10% of human pregnancies), which are thought to occur as the result of Meiosis I and II errors, defective or inappropriate recombination, premature homolog separation, and defects in sister chromatid cohesion. Mutations in MMR genes have been found in ~50% of hereditary non-polyposis colorectal cancer (2-7% of all colon cancers) patients and are thought be linked to infertility, underscoring the importance of obtaining new mechanistic understandings and molecular tools to establish allele pathogenicity.